Health Professions Education and training for strengthening the health system and services in Uganda

Project Summary
There has been a chronic shortage of health professional workers in sub-Saharan Africa, which has 15% of
the world's population, 25% of the global disease burden and 3% of the global workforce. Whereas
Uganda's health indices like infant and under-5 mortality rate have improved, they remain unacceptably
high with the health workforce as a key bottleneck to provision of appropriate health services. The
MakCHS, MEPI award (2010), scored several successes including building research capacity by training
PhDs, master's and faculty. In addition it improved the quantity, quality, and retention of medical graduates
in Uganda through supporting the establishment of a medical school, identifying competencies for medical
education and improving institutional systems for education and research. However, despite these
achievements, there are several old and new emerging challenges that need a sustained training of more
health workers. Also Ugandan's rapid population growth rate of 3.3 % with a high total fertility rate of 6.0 is
creating a huge demand for health workers. Further because of the many gains in HIV care, HIV has
become a chronic condition compounded with the associated increase in non-communicable diseases. This
rapidly evolving epidemiological transitions have further strained the already weak Ugandan health care
system. This project will build on the gains of the MEPI, address the challenges, and leverage on exiting
opportunities. Our goal is to improve service delivery of the Ugandan health systems through strengthened
health professional interdisciplinary education and research training. Our overall hypothesis is that
strengthening the consortiums health professional education capacity will lead to increased numbers of
health professionals, with the competencies to address the critical health needs of Uganda. We will test the
overall hypothesis through the following aims. 1) Enhance Health Professions' Education and training to
produce health professionals who are competent to address the priority health needs of Uganda. 2)
Strengthen the capacity of graduating health professional students to remain and practice in Uganda, serve
as faculty and or conduct research related to HIV/AIDs and other health priorities. 3) Enhance institutional
systems to sustain transformative health professions education in Uganda through the engagement of
stakeholders, networking, and enhancing institutional systems. The project will strengthen health
professional education, research and training capacity in Uganda with special emphasis on nursing using
innovative models including e-Learning and simulation methods. . We shall monitor and evaluate our
interventions, to provide evidence for best practices. This consortium represents a strong innovative
partnership between medical and nursing education institutions in Uganda and the US.

Public health relevance
Project(narrative(( ! A scale up of the training of health professionals will be sustained through a partnership between medical and nursing education institutions in Uganda and US so as not to upend the improved health indicators observed so far in Uganda. High population growth and the evolving epidemiological transition in Uganda are creating new challenges and higher demand for health professionals. We propose to build on the gains of the MEPI, to improve service delivery, by strengthening, research, health professional inter-disciplinary education, with special emphasis on nursing using innovative models !